Integrative approaches for predicting protein interactions and applications

The ability to accurately predict protein interactions is critical for the mechanistic investigation of many biological
processes and for rational therapeutic development. Over the past decades, methods ranging from
physicochemical-based approaches to template-based and machine learning-based approaches have
significantly advanced protein complex structure prediction. With the power of recent tools like AlphaFold2 and
AlphaFold3, enormous progress has been achieved. Yet, there are several unmet, important challenges that
remain unsolved beyond the existing computational methods, including AlphaFold. We will take advantage of the
flexibility of the five-year R35 funding mechanism to address five different challenges under the umbrella of a
common theme: developing novel computational methods to predict protein interactions and their complex
structures by integrating principles of physics, bioinformatic approaches, and machine learning technologies. I will
also continue to collaborate closely with experimental colleagues at our university, validate our computational
methods and predictions, and explore potential therapeutic applications for the treatment of diabetic wounds.
Goal #1: Predicting disordered protein-protein interactions.
Goal #2: De novo design of peptides targeting the protein-protein interaction (PPI) interface.
Goal #3: Development of novel peptide inducers of NRF2 that target the Keap1-NRF2 interface with potential
applications for treating diabetic wounds.
Goal #4: Development of a Graph Neural Network (GNN)-based deep learning algorithm for antibody-antigen
interface True/False classification and multiple point mutation assessment.
Goal #5: Development of GNN-based polarized protein-specific charges for protein-ligand docking and simulations.
During the past four years since the funding of this R35 in May 2020, my lab has published 20 peer-reviewed
papers supported by this grant on predicting protein interactions and lead discovery, including papers in high-
impact journals such as PNAS and Nature Communications. I have additional five research manuscripts submitted
to peer-reviewed journals (currently under review). We have also filed three pharmaceutical patent applications
and obtained one software copyright, along with three webservers. Our software has been freely distributed to
academic users from 22 countries across every continent. My team consistently ranks among the top in prestigious
and highly competitive international competitions for blind protein-protein and protein-ligand structure predictions.
All source codes developed from this project will be freely accessible to academic users and all webservers are
freely accessible to everyone.

Public health relevance
The accurate prediction of protein interactions is essential for unraveling the mechanisms underlying numerous biological processes and for the development of targeted therapeutics. In this proposal, we aim to address the pressing need for novel computational tools that can predict interactions involving disordered proteins, facilitate in silico peptide screening, and more. Our goal is to leverage these advancements to identify and explore potential peptide-based treatments for diabetic wound healing.